Tracking plasmid spread and transmission in the hospital: A novel tool for infection prevention and control

Project Summary
Despite recent progress in reducing the incidence of healthcare-associated infections (HAIs), the Centers for
Disease Control and Prevention estimated that 687,000 HAIs occurred in U.S. acute care hospitals in 2015
and that the HAI prevalence on a given day was one in 30 patients. An estimated 72,000 patients died with
HAIs during their hospitalization. In addition, outbreaks in hospitals remain a serious problem but the vast
majority of hospitals use antiquated and ineffective methods to detect them. We established the Enhanced
Detection System for Healthcare Acquired Transmission (EDS-HAT) (R01AI127472), which combines bacterial
whole genome sequencing (WGS) surveillance (as opposed to reactive WGS) to detect outbreaks with data
mining (DM) of the electronic health record (EHR) and machine learning (ML) to identify the responsible
transmission routes. We have demonstrated that EDS-HAT detects both serious outbreaks that were otherwise
unrecognized and novel transmission routes and therefore now run the system in real time. Plasmids carried
by bacteria frequently encode genes that confer resistance to antimicrobial agents. When patients or hospital
environments are co-colonized with two bacterial species, these settings provide the opportunity for plasmid
transfer to occur from a species carrying a plasmid to one that does not. The species with the newly acquired
plasmid can then be transmitted to another patient, a combination of events we call transfer to transmission
(T2T). Importantly, T2T events are not captured by traditional WGS analysis or EDS-HAT. In this R21
application, we propose to leverage the success and infrastructure of EDS-HAT by developing methods for
detection of T2T events and determining the potential utility of incorporating surveillance for these events into
EDS-HAT. In Aim 1, we plan to develop and validate optimal laboratory and bioinformatics approaches for
real-time identification of T2T events in the hospital. In Aim 2, we will determine the feasibility and potential
impact of real-time monitoring for T2T events and determining the responsible transmission routes. Actionable
T2T events will be reported to our infection prevention team so that interventions can be developed to interrupt
transmission. These aims will be accomplished by a team with expertise in infectious diseases epidemiology,
outbreak investigation, infection prevention and control, microbial genomics and genomic epidemiology. If
successful, this research will lead to a novel infection prevention tool. The proposed research is highly
translational and will improve patient safety through incorporation of innovative genomic and computational
approaches for identifying otherwise unrecognized T2T events.

Public health relevance
Project narrative Whole genomic sequencing (WGS) surveillance has been shown to detect serious outbreaks that are otherwise unidentified by traditional infection prevention methods. Bacterial plasmids often contain multiple genes that encode for antimicrobial resistance and be readily transferred between bacterial species, which can then be transmitted between patients (transfer to transmission [T2T]), events that are not detected by traditional genomic epidemiologic methods. In this application, we propose to develop the methods for detecting T2T events and determine their utility as part of WGS surveillance in the hospital.